Investigating COUP-TFII in human vein development

PROJECT SUMMARY
The cardiovascular system is one of the earliest systems to develop and is critical for the survival of nearly all
tissues and is comprised of four vessel types: arteries, veins, lymphatic vessels, and capillaries. Although they
are all lined internally with a single-cell layer of endothelial cells (ECs), these ECs have cell identities specific to
their vessel. Little is known about how the endothelial cell subtypes specialize, including veins. Disruptions in
vein EC specialization and function can lead and/or contribute to conditions including arteriovenous
malformations, cancers, or metabolic diseases.
Previous research in mouse and zebrafish models revealed that a transcription factor, COUP-TFII, is
required for vein EC identity specification. COUP-TFII is considered an orphan receptor since a physiological
ligand has not been identified and is considered a key marker for venous identity. However, it remains unclear
whether it is required for human vein development and critical aspects of its mechanisms of action are unknown.
This is due to the lack of human culture systems for vein EC development and the difficulty of obtaining enough
vascular cells for biochemical experiments from model organism blood vessels. Recently, our collaborators in
the labs of Drs. Lay Teng Ang and Kyle Loh have established a stem cell differentiation protocol for vein and
artery ECs from human pluripotent cells. The protocol results in the efficient (>85%) generation of highly pure
vein ECs and recapitulates the steps of early embryonic cell differentiation. Leveraging this protocol, I aim to
study COUP-TFII during human vein development.
In Aim 1, I will establish if COUP-TFII is required for human vein EC specification, and if so, what protein
domains of COUP-TFII are required. I will use and generate COUP-TFII loss-of-function CRISPR-modified
human embryonic stem cell (hESC) lines to determine if markers of venous identity are disrupted in their gene
and protein expression. I have already found that vein ECs generated from a COUP-TFII knockout hESC line
has differential gene expression when compared to wildtype and that this is recapitulated in the COUP-TFII
ligand binding domain truncation, suggesting that ligand binding plays an important role in vein EC development.
In Aim 2, I will investigate if COUP-TFII regulated genes are required for venous EC specification, and what, if
any, protein binding partners COUP-TFII is interacting with during human vein EC development. To do this, I will
use COUP-TFII hESC lines that are tagged with FLAG, BioID and TurboID to perform immunoprecipitation and
mass spectrometry experiments. Lastly, I will identify COUP-TFII ligands in Aim 3 through proximity labeling and
mass spectrometry. Together, these aims will provide insight into the molecular dynamics of COUP-TFII in
human vein EC development and allow me to gain technical and intellectual skills in experimental design and
prepare for competitive postdoctoral positions.

Public health relevance
PROJECT NARRATIVE Knowledge of human blood vessel formation, including veins, is crucial for successfully vascularizing engineered tissues in regenerative medicine and effectively treating organs affected by vascular diseases. However, the processes guiding the development of human veins remain poorly understood due to the scarcity of samples and the lack of relevant model systems. Here, I propose to study COUP-TFII, a transcription factor implicated in venous differentiation in other species, and its mechanisms of action by leveraging a recently developed human pluripotent stem cell differentiation protocol with the long-term goal of identifying new therapeutic pathways.